Mentored research in the intersection of kidney and cardiovascular disease

ABSTRACT
I am a mid-career nephrologist, a newly promoted Professor, the holder of Arthur Stach Endowed
Professorship and the Director of Nephrology Clinical and Research Education in the Division of Nephrology at
the University of Washington (UW). I have been a NIDDK-funded physician-scientist since the completion of
my fellowship in 2010; and have an active patient-oriented research program that focuses on the intersection
of kidney and cardiovascular disease. My work encompasses epidemiological studies, mechanistic studies,
and clinical trials all focused on the pathophysiology, diagnosis, risk stratification and treatment of
hypertension, heart failure and cardiac arrhythmias in patients with chronic kidney disease, acute kidney injury
and kidney failure (treated with dialysis or kidney transplant). I am currently the PI of three NIH R01s, the co-
Director of the UW Nephrology NIDDK T32, co-I on two NIH U01s and the PI of two NIH administrative
supplements. One of the greatest joys and privileges of my career to date has been the opportunity to serve as
mentor. My success as a mentor is measured by my mentee’s success.
My current and previous grants have provided numerous rich opportunities for training for post-doctoral
students, residents and fellows. I have been a mentor for 24 talented individuals since 2010, including 63%
women, 50% Asian American persons, 30% persons underrepresented in medicine or science by race,
ethnicity, gender identify and family educational status. Of these, 63% of my mentees remain in academia and
continue in scholarship or research. The work of these mentees has been productive, yielding >40 first author
publications and ten NIH or foundation grants.
There is a critical need to increase mentorship for individuals from diverse backgrounds. It is well known that
advances in NIDDK-focused diseases are in crisis as fewer physician and scientists choose to pursue research
careers. In particular, diverse research teams are needed to address racism and disparities in medicine and
science. Mentorship is a critical factor cited by students for inspiring their interest in scientific careers. Locally,
the UW, located in Seattle, WA, is unique in its mission to attract trainees from across a five-state region of
Washington, Wyoming, Alaska, Montana and Idaho, who are diverse by race (including American Indian and
Pacific Islander), ethnicity, sex, gender, geography (many from rural areas), ability, LGBTQ+ and
socioeconomic status. Coupled with established outreach programs at UW and the sizable pool of post-
doctoral trainees from these diverse backgrounds, there is tremendous opportunity to cultivate the next
generation of NIDDK diverse scientists in this region. I am committed to mentoring persons from backgrounds
underrepresented in medicine and science to increase the diversity of the future NIDDK biomedical scientific
workforce. This award will provide key resources, training and professional development that will enhance my
ability to serve as an effective mentor for post-doctoral trainees from diverse backgrounds.

Public health relevance
PROJECT NARRATIVE I am a nephrologist, physician-scientist and Professor at the University of Washington. I have a strong track record of NIDDK funding, leadership in education and mentorship. This award will provide key resources, training and professional development that will enhance my ability to serve as an effective mentor for post- doctoral trainees from backgrounds underrepresented in medicine and science.